Lysosome Trapped FAP-Targeted Theranostics for Pancreatic Cancer

ABSTRACT
Pancreatic ductal adenocarcinoma (PDAC) is a lethal, treatment-refractory malignancy characterized by
fibroblast-rich stroma. While external beam radiation therapy (EBRT) is a staple in the current treatment of PDAC,
its therapeutic efficacy is limited by normal tissue toxicities and its inability to target metastatic disease. Targeted
radionuclide therapeutics (TRTs), particularly low-molecular-weight carriers, offer an avenue to improve the
deliverable radiation dose and therapeutic efficacy compared to EBRT by selectively targeting tumors (both
primary and metastatic) and substantially reduce non-target toxicities. The fibroblast activation protein-α (FAP)
is selectively expressed on tumor-associated fibroblasts in the tumor microenvironment (TME) of PDAC (~75%)
and other malignancies. Several clinical imaging studies have validated the potential of small molecule, FAP-
targeted constructs (e.g., 68Ga-FAPI-46). However, the therapeutic translation of FAP-TRTs has failed mainly
due to their low tumor-residualization, which diminishes deliverable therapeutic doses, therapeutic efficacy, and
clinical potential. Recently, we have developed an endolysosomal trapping approach reliant on adduct formation
with cysteine protease to increase tumor residualization of TRTs substantially. Using this adduct formation
approach, the goals of this proposal are to optimize 177Lu- and 225Ac-FAP-targeted TRT constructs, obtain a
greater understanding of how PDAC biology impacts adduct formation, demonstrate our construct's therapeutic
efficacy and safety in PDAC models, understand the impact of FAP-TRTs on the PDAC tumor microenvironment
and compare and contrast the biological effect of 177Lu (β-) vs. 225Ac (α) based FAP-TRTs. Another challenge for
FAP-targeted therapies emerges from its heterogeneous expression and the inadequacy of preclinical models
to recapitulate variabilities in FAP expression. We have generated a panel of human immortalized patient-derived
pancreatic fibroblasts (iPDPFs) that recapitulate CAF heterogeneity and variable FAP expression. We have also
developed unique CAF-tumor cell co-implantation models that result in FAP high or FAP low tumors. We
hypothesize that incorporating cysteine protease trapping agents (CPTAs) into the structure of FAP-targeted
agents (FAPTAs) will allow the formation of intracellular adducts capable of delivering higher therapeutic efficacy
through enhanced PDAC-specific retention. To test this hypothesis, two specific aims are proposed. Aim 1
focuses on optimizing 177Lu/225Ac-CPTA-FAPTAs and examining adduct formation and distribution in PDAC
models. Studies in Aim 2 are designed to evaluate the therapeutic efficacy of 177Lu/225Ac-CPTA-FAPTAs and
investigate the impact of FAP-TRT therapy on CAF heterogeneity. We propose to employ cutting-edge
approaches and models to study the biodistribution, cellular uptake and trafficking, adduct formation, dosimetry,
and therapeutic efficacy of 177Lu/225Ac-CPTA-FAPTAs. Successful completion of the proposed studies will
provide the critical data required to progress the novel FAP-TRTs toward regulatory approval and initiation of
clinical trials in the future.

Public health relevance
Project Narrative While fibroblast activation protein-α (FAP) has emerged as a potential target for pancreatic ductal adenocarcinoma (PDAC) imaging using small molecule radiopharmaceuticals, the translation of FAP-targeted radionuclide therapy (FAP-TRT) has, thus far, failed. The proposed studies aim to develop, optimize and characterize a novel class of FAP-targeting agents (FAPTAs) based on lysosomal adduct formation and trapping to enhance tumor residualization and evaluate their efficacy in novel models recapitulating PDAC tumor microenvironment and heterogeneous FAP expression observed in human disease. This proposal will result in a novel class of FAPTAs that can deliver clinically relevant radionuclides (177Lu & 225Ac) to image and treat primary and metastatic PDAC.